HIV Immunobiology: From Infection to Immune Control

DESCRIPTION (provided by applicant): This application is to request support for a Keystone Symposia meeting entitled "HIV Immunobiology: From Infection to Immune Control", organized by Didier Trono, Dana H. Gabuzda and Robert F. Siliciano, which will be held in Keystone, Colorado from March 22 - 27, 2009. This meeting will highlight the latest breakthroughs in basic HIV research, ranging from the molecular bases of HIV replication to the host genetic determinants influencing viral spread and disease susceptibility;and from the intricacy of the interaction between HIV and the immune system to the most promising progress in therapeutic development. The meeting will identify new levels of possible intervention to control the progression of HIV-induced disease and, more generally, deepen our understanding of the intimate interaction between retroelements and human hosts. Dynamism will be ensured by having concise, up-to-date talks rather than lengthy lectures, by giving ample room to speakers chosen from the abstracts, and by a close coordination with the concurrent meeting on Prevention of HIV/AIDS. Opportunities for interdisciplinary interactions will be significantly enhanced by the concurrent meeting, which will share a keynote address and three plenary sessions with this meeting. The Keystone Symposia meeting on HIV Immunobiology: From Infection to Immune Control will explore our current understanding of interactions between HIV and the immune system, from the dual perspectives of AIDS pathogenesis and anti-HIV immune responses. This symposium will gather experts in HIV immunology, HIV molecular biology, basic immunology, along with geneticists and vaccines scientists, to address issues of central importance to understanding the disease and paramount to the development of new therapeutic and preventive measures.

Public health relevance
PROJECT NARRATIVE The Keystone Symposia meeting on HIV Immunobiology: From Infection to Immune Control will explore our current understanding of interactions between HIV and the immune system, from the dual perspectives of AIDS pathogenesis and anti-HIV immune responses. This symposium will gather experts in HIV immunology, HIV molecular biology, basic immunology, along with geneticists and vaccines scientists, to address issues of central importance to understanding the disease and paramount to the development of new therapeutic and preventive measures.